Role of maternal Treg cells in the induction of neonatal tolerance

Project Summary
Food allergy (FA) is a growing public health concern. The effects of maternal immune responses on the induction
of regulatory T (Treg) cell-mediated tolerance in offspring are poorly understood. We have recently found that
maternal sensitization with allergen [ovalbumin (OVA) or peanut] prevented FA responses in murine offspring in
response to epicutaneous sensitization and oral challenge with the same allergen, as indicated by a decrease
in the levels of food anaphylaxis, allergen-specific immunoglobulin (Ig) E, serum mouse mast cell proteinase 1,
and intestinal mast cell expansion. This protection was associated with an increase in the levels of IgG and
allergen immune complexes (IgG-IC) in breast milk. Neonatal Fc receptor (FcRn)-dependent transfer of maternal
IgG-IC via breast milk and IgG-IC presentation by offspring CD11c+ dendritic cells induced allergen-specific Treg
cells in offspring. Breastfeeding by OVA-sensitized mothers, or maternal IgG-IC supplementation induced
neonatal tolerance. Consistently, human breast milk collected from non-atopic mothers contained IgG-IC and
induced tolerance in humanized FcRn mice. These results indicate that maternal immune factors, especially IgG-
IC, in breast milk are critical for the induction of Treg cells and control food-specific tolerance in neonates. Wild-
type (WT) offspring adopted and nursed by OVA-exposed Rag2-/- mothers showed failure of tolerance towards
FA as compared to WT controls, associated with a decrease in the frequencies of allergen-specific Treg cells in
offspring. IgG-IC supplementation of OVA-exposed Rag2-/- mothers failed to rescue neonatal food tolerance in
adopted WT offspring, suggesting that IgG-IC require additional maternal milk factors to successfully induce
neonatal food tolerance. Transfer of maternal cells to infants through milk has been recognized, however, the
presence of maternal Treg cells in milk are poorly described. We found that maternal Treg cells were transferred
to offspring via milk and accumulated in the intestine and spleen of offspring. Depletion of maternal Treg cells
during breastfeeding period resulted in failure of neonatal tolerance in the presence of IgG-IC. Further, we found
that Treg cells are present in human milk. These results suggest that maternal Treg transfer via milk has a
significant role in shaping the neonatal immune system and the susceptibility to FA. The goals of this proposal
are to establish the phenotype of maternal Treg cells in milk and to decipher the role of these cells in regulating
food-specific tolerance in neonates. We hypothesize that maternal Treg cells transferred through milk act in
synergy with maternally transferred allergens (IgG-IC) during a specific time window in the perinatal period to
successfully induce neonatal food tolerance. We also hypothesize that maternal milk Treg cells exhibit unique
phenotype and gene expression profiles as compared to systemic Treg cells. Lastly, we hypothesize that
maternal milk Treg cells exhibit alterations in gene expression profiles that are associated with the development
of FA in offspring that reflect a dysregulation of the suppressive Treg cell phenotype.

Public health relevance
Project Narrative Using a mouse model and human milk, we recently found that breastfeeding by mothers who mounted immune responses to food, induce regulatory T immune cells that mediate tolerance in children and protect them from food allergy, a major health problem that affects 8% of children and 5% of adults in the U.S. We also found that maternal regulatory T cells were transferred to offspring via milk in mice and in human, raising a possibility that these cells may influence neonatal immune system and the susceptibility to food allergy. In this proposal, we aim to determine the profiles of the maternal regulatory T cells, and to establish their role in regulating tolerance to food in children, and how they are modulated in food-allergic population, therefore, unveiling the currently underinvestigated mechanisms that may control neonatal food tolerance.